Computational Design of Inhibitor Specificity

DESCRIPTION (provided by applicant): The development of new approaches to treat rapidly evolving viral infections is an important area of research. This project will pursue general methods for the development of drug therapies that lead to inhibitors that avoid resistance in the context of AIDS, yet broadly applicable to infectious disease and cancer. We will continue to develop and improve the substrate envelope hypothesis, will develop and apply inverse computational design methods for small-molecule ligands, will study failures of the substrate envelope hypothesis to improve the approach, and will develop alternative approaches related to the substrate envelope hypothesis in the context of HIV-1 protease through a collaborative effort with experimental groups expert in organic and medicinal chemistry, enzyme assays, protein crystallography, and virology. Because essentially all therapies developed for infectious disease and cancer are limited by the selection of resistant variants, strategies for avoiding or a least delaying resistance that are generally applicable would have tremendous impact on drug development. This project will understand and improve the substrate envelope and related approaches in the well studied HIV-1 protease, but the methods developed will be broadly applicable to target-based infectious disease and cancer drug resistance. The substrate envelope hypothesis maintains that inhibitors that reside within the volume shared by substrates are less susceptible to resistance mutations, because such mutants must still process substrates. Preliminary work has demonstrated some success and shown some limitations of the substrate envelope hypothesis, and the proposed project will further test and develop the substrate envelope hypothesis in the context of HIV-1 protease. Extensions of the substrate envelope hypothesis include other modes of being substrate-like besides the geometric criteria of occupying the common substrate volume. Our previous work includes successes and failures of the substrate envelope hypothesis. The failures are molecules we designed that when synthesized bind wholly within the substrate envelope but fail to bind robustly across a panel of drug-resistant variants. By studying these molecules and substrates bound to wild type and drug-resistant variants, we will seek a mechanistic understanding of failures of the substrate envelope hypothesis, which will use to develop improved versions of the substrate envelope hypothesis. Finally, advances in deep sequencing technology make it possible to consider mapping the functional mutational space of candidate targets, and using the functional mutational space as a guide to the development of inhibitors that are not susceptible to resistance mutations. This project will develop and study methodology for using the functional mutational space as a basis for the design of inhibitors that avoid resistance. We will compare the success of this approach to the substrate envelope approach, noting that the new approach is applicable to targets whether they are enzymes or not, whereas the current state of the substrate envelope hypothesis is applicable to enzymes only.

Public health relevance
PUBLIC HEALTH RELEVANCE: Current medical drug therapy for infectious disease and cancer is limited by the emergence of resistance, in which a previously effective therapy loses its effectiveness, often through mutations in the target. This project aims to study methods for developing new therapies that prevent, or at least significantly delay, the emergence of resistance. Initial work will target the HIV protease, which is the target of some current therapies, but for which the emergence of resistant strains remains a significant problem.